High throughput identification of bacteriophages and their hosts with single-cell transcriptomics

PROJECT SUMMARY
Bacteriophages (phages) are bacterial viruses that can influence human health by modulating bacterial
populations. As such, phages have been associated with a number of diseases linked to bacterial dysbioses like
inflammatory bowel disease. The number of known DNA and RNA phages has exponentially increased by more
than 10,000-fold over the past 10 years due to rapid advances in metagenomics. However, since this culture-
independent method does not preserve phage-host relationships, the hosts of many phages are unknown. This
prevents experimental investigation of the mechanistic connections between phages, bacteria, and human
disease. A number of phage-host pairing tools are available but lack the throughput and efficiency to rapidly
screen thousands of bacterial cells in complex communities like the human enteric microbiome. The overall goal
of this proposal is to define phage-host pairs in the context of complex communities. I will achieve this goal by
establishing an innovative, high throughput phage-host pairing tool for complex, naturally occurring communities.
Specifically, I will use an innovative strategy based on prosingle-cell (sc) RNA-sequencing (scRNA-seq) to rapidly
screen complex communities for individual cells carrying phage-derived RNA transcripts, which are generated
by DNA and RNA phages. However, current prokaryotic scRNA-seq protocols are not designed for profiling
phage infections or multi-species scenarios. My preliminary data demonstrate that I can successfully recover the
transcriptomes of noninfected and phage-infected bacterial species in a 10-species mixture using a scRNA-seq
protocol originally intended for noninfected monocultures, which has not been previously shown in the literature.
Therefore, to establish and implement a scRNA-seq-based, phage-host pairing tools for complex communities,
I will first (Aim 1) adapt a published prokaryotic scRNA-seq protocol to identify RNA and DNA phage-infected
cells in a synthetic community of bacteria representative of the human enteric microbiome to demonstrate proof
of concept. (Aim 2) I will then apply my optimized scRNA-seq protocol to human stool samples to identify phage-
host pairs. I will use multiple approaches to validate a subset of phage-host pairs (Aim 3) identified in Aim 2,
including fluorescent in situ hybridization combined with whole genome sequencing and establishment of culture
models. Collectively, this work will be instrumental in advancing our ability to functionally study phage-host
interactions in the context of human health and disease.

Public health relevance
PROJECT NARRATIVE Bacteriophages (phages) have been repeatedly associated with human disease. Since the majority (>99%) of these phages have been discovered by culture-independent metagenomics, their bacterial hosts are unknown, which prevents a mechanistic explanation for how interactions between phages and bacteria influence human health. This proposal will establish a high throughput phage-host pairing tool based on single-cell prokaryotic transcriptomics to facilitate the development of culture models to study phage-host interactions.